Cellular FM-radios: seeing, probing, and perturbing single-cell protein activity dynamics in biological systems with frequency-barcoded spatiotemporal signaling circuits

Project Summary/Abstract
Biology is powered by the self-organization of protein activities in space and time, allowing cells to build
emergent behaviors like motility and information-processing out of biochemical reactions. In multicellular
systems, proper execution of these single-cell behaviors is critical for processes like development, immune
surveillance, and wound healing. As a result, many human diseases have their origin in the dysregulation of
protein activity dynamics, including cancer and autoimmune disorders. There is thus a pressing need to
understand both the normal operation of the cell’s dynamic protein-based hardware and how it fails in diseased
contexts. The proposed research describes an innovative strategy for installing “cellular radio” circuits into cells
that generate a protein-based frequency-modulatable (FM) barcoded signal. This signal can then be used for
visualizing, probing, and perturbing the protein activity dynamics of single cells in any complex biological setting.
Our approach is enabled by our successful implementation of a genetically-encoded orthogonal patterning circuit
(MinDE) in human cells that can produce an unprecedented breadth of cell-scale spatiotemporal protein
dynamics and patterns. The fast oscillations of MinDE circuits generate a unique single-cell FM-barcoded
fluorescent signal that can be locked on to and spectrally separated from other overlapping cells using frequency-
domain image processing tools we have developed based on Fourier, Wavelet and Hilbert Transforms. Using
protein-engineering and synthetic biology, we will develop a general platform for designing MinDE circuits that
can be connected to any dynamic protein activity in the cell. This will allow for MinDE circuits that can read out
and broadcast multiple protein activities simultaneously on a cell’s unique FM-barcoded signal, enabling us to
unambiguously track how the internal state of individual cells changes as multicellular processes evolve; and
MinDE circuits that can act as genetically-encoded control signals that perturb the dynamics of any target protein
of interest, enabling dynamic profiling of key nodes of cell behavior by microscopy and high-throughput
sequencing based assays. We will design and apply specific MinDE circuits to investigate oncogenic signaling
dynamics and aberrant information processing in cancer cells and tumor organoids, asking how different
upstream oncogenic driver mutations corrupt downstream signaling dynamics through ERK, mTOR, and PKA
kinases. In parallel, we will generate MinDE circuits that stimulate ERK, mTOR, or PKA signaling at different
timescales to define how temporal constraints on signal transmission are corrupted in different oncogenic
backgrounds and their impact on tumor organoid development. While the applications in this proposal focus on
oncogenic signaling, our platform is easily applied to any dynamic protein activity of interest. Our work will thus
establish a new paradigm for understanding and engineering dynamic protein activities in biological systems,
providing new insights into basic and translational biology with high potential for therapeutic applications.

Public health relevance
Project Narrative Many human diseases arise from dysregulation of protein activity dynamics that drive single-cell behaviors underpinning critical multicellular functions. The proposed research will develop genetically-encoded “cellular radio stations”: synthetic protein circuits that generate a unique frequency-modulatable (FM) barcoded signal in the cell that can be used to unambiguously visualize, probe, and perturb single-cell protein activity dynamics in any complex biological setting. By applying this technology to investigate oncogenic signal processing across cancer cells and tumor organoids, we will advance our understanding of fundamental biology and identify new approaches for the diagnosis and treatment of human disease.